Basic and applied research on extinction bursts when treating problem behavior

Project Summary
Results of epidemiological studies and meta-analyses indicate that treatments for destructive behavior based
on functional analyses, like functional communication training (FCT), typically reduce destructive behavior by
90% or more and are much more effective than other treatments. However, these treatments involve
extinction, which can produce extinction-induced adverse side effects. The most common side effect of
extinction involves an increase in the frequency or intensity of the target response at the start of treatment,
called an "extinction burst," which can place the patient and others at significant risk of harm. Prior theories on
extinction bursts fail to account for the dynamic nature of these phenomena, and the basic behavioral
processes that control bursts remain poorly understood. Our clinical and animal pilot data strongly suggest
that our novel refinement of the generalized matching law, called the temporally weighted matching law
(TWML), which incorporates reinforcement time and reinforcement history into the quantitative model, (a) fits
our pilot data quite well, (b) resolves prior discrepancies between basic and clinical studies on bursts, and (c)
identifies novel clinical procedures for preventing extinction bursts. The long-term goals of the project are to
test our quantitative model of extinction bursts under typical clinical conditions to demonstrate its potential for
improving treatment of destructive behavior and in the lab under a wider range of highly controlled conditions
to provide a formal quantitative assessment of the predictions of the theory, evaluate its boundary conditions,
and identify potential future clinical refinements. The specific aims are to demonstrate that large, discriminable
drops in the rate (Spec. Aim 1), magnitude (Spec. Aim 2), and quality (Spec. Aim 3) of reinforcement when
extinction or FCT are introduced increase the prevalence and magnitude of extinction bursts and that
preventing such drops in the rate, magnitude, and quality of reinforcement will prevent or mitigate extinction
bursts for both applied and basic research participants (i.e., humans referred for destructive behavior and rats,
respectively). Specific Aim 4 will examine potential interactions between the variables of rate, magnitude, and
quality of reinforcement predicted by the TWML to test current and inform future clinical refinements. The
effects of reinforcement rate, magnitude, and quality will be manipulated and evaluated using a within-subjects
design with the human clinical participants and using a randomized group design with lab rats, and the rate of
destructive behavior (humans) and lever pressing (rats) will be the primary dependent variables.

Public health relevance
Project Narrative This project empirically examines novel predictions about harmful extinction bursts, which are poorly understood and impede treatment success with many behavior disorders. It seeks to fill existing gaps in basic/theoretical knowledge about extinction bursts through a rare and close collaboration between basic and clinical scientists. The project closely aligns basic and clinical research to increase the clinical relevance of basic studies, which in turn should lead to more effective clinical treatment of extinction bursts.